Exploring Role of Astrocytic adhesion GPCR Remoulade in Neuronal Remodeling

Project Summary
Nervous systems are initially assembled with excess neurons and synaptic connections, but these are later
refined whereby exuberant neurons, individual neurites, or synapses are eliminated, which is believed to drive
optimization of neuronal circuitry for mature brain function. Failures in proper neuronal remodeling can result in
significant neurodevelopmental disorders, including Autism Spectrum Disorders, schizophrenia, and epilepsy.
Glial cells play a critical role in the circuitry refinement, helping neurons execute remodeling by removing
neuronal debris, although the mechanisms mediating these processes are not well understood.
To address this, I will explore the role of a novel pathway in Drosophilia, Remoulade (Remo), ortholog of the
mammalian orphan adhesion GPCRs Gpr124 and Gpr125. Our preliminary data has shown loss of Remo in
astrocytes results in a failure of neurite refinement in a specific subclass of neurons, termed Beat-VaM neurons,
which undergo local pruning (i.e. elimination of axon/dendrites and synapses followed by regrowth of the
pruned parent neuron). In Aim 1 I will perform a detailed genetic analysis of Remo in the activation of pruning
and elimination of neuronal debris in Beat-VaM neurons. In Aim 2, by examining live and fixed tissue samples, I
will define the precise role for Remo in the transformation of astrocytes into phagocytes, recognition,
internalization and processing of neural debris for elimination; and define the localization of Remo throughout
this process. Finally, in Aim 3, I will explore the role of Remo in other glial phagocytic events, including
remodeling of other neurons during development, or after axonal injury (i.e. axotomy). Together, these studies
will provide exciting new insight into the mechanisms by which glia help activate and execute neuronal
remodeling and responses to injury in vivo.
My goals as a postdoctoral fellow are to a) develop technical and intellectual approaches needed to start my
own independent research lab studying neurodevelopment and b) learn the tools and techniques needed to
utilize Drosophila to understand the contributions of glia to neurodevelopment in deep molecular terms. My
proposed work has excellent training potential—I will learn a new genetic model system, become an expert in
neurodevelopmental studies in Drosophila, and learn cutting edge imaging and genome engineering
approaches for use with this system. The additional training activities proposed during my fellowship will also
enhance my quantitative and analytical skills, improve my ability to communicate my work, and engage in
effective mentorship. Collelectively, this fellowship will help prepare me to successfully transition towards a
career as an independent investigator.

Public health relevance
Project Narrative Understanding the pathways glia utilize to sculpt neuronal connections is essential to understand how they regulate normal development and may drive disease. Glia are dynamic, influential participants in many developmental processes, however, the precise cellular clues and molecular pathways glia utilize to prune neurons (i.e. remove unneeded branches) are not well defined. The experiments described in this proposal aim to understand the role of a novel pathway in the recognition of neuronal debris, which should provide insight that may help us understand human neurodevelopmental and neurodegenerative disease.